Multivariate statistical methods, flow cytometry, and network modeling.

DESCRIPTION (provided by applicant): In many areas of biological or medical research, investigators are faced with the task of analyzing data sets that can be described as large sample, moderate dimension. An important example, which is the specific focus of this project, is multi-parameter flow cytometry where the number of data points is in the range of tens of thousands to several millions, and each data point can provide measurements on multiple variables (5 to 60). New statistical tools are needed to analyze and visualize this data, and to address the associated hypothesis testing and modeling challenges. The goal of this research is to develop new statistical methods for this type of multivariate data, and based on these methods, to create and provide more effective data analysis and interpretation tools for multi-parameter flow cytometry. First we will develop a new approach to multivariate density estimation based on the approximation of the density by simple functions. These estimates are essentially histograms based on data adaptive partitions of the basic multivariate domain. The aim is to attain effective learning of these partitions using methods with strong theoretical justification and good empirical performance. We will also implement and further develop these methods for the analysis of multi-parameter flow cytometry data. Particular attention will be paid to mass cytometry which is a new cytometry modality that can greatly increase the number of variables measured per cell, as compared to classical polychromatic flow cytometry. The aim is not only to improve primary analysis tasks such as cell population identification, but also to develop new methods for downstream analysis tasks such as graphical modeling of the variables being analyzed. The methods will be disseminated though distribution of computer programs and also though web service.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this research is to develop new statistical methods for nonparametric learning from large amount of multi-dimensional data points. Based on these methods, we will create and provide more effective data analysis and interpretation tools for multi- parameter flow cytometry. There are two broad impacts of this research. First, the new analytical and computational methods will open up novel ways to use flow cytometry in many areas of studies in current biology and medicine. Second, the density estimation methods and software resulting from this research have general applicability beyond flow cytometry analysis, and can be used as building blocks to design new statistical analysis and modeling tools useful in other areas.